A Resource Center for Tetrahymena Thermophila

Project Summary / Abstract
This proposal seeks continued funding for the Tetrahymena Stock Center in order to maintain its current
operations, expand its capabilities and ensure its sustainability as a resource for the community at-large. A key
model for eukaryotic cell and molecular biology, Tetrahymena thermophila has been instrumental to our
understanding of a wide range of biological phenomena with direct relevance to human health and disease
including cancer, infertility, aging, respiratory and neuroendocrine dysfunction. Tetrahymena has also shown
great promise as a platform for the production of recombinant proteins, including vaccine antigens and difficult-
to-express human ion channels, and serves as a useful teaching tool in K12 and undergraduate classrooms.
Specifically, our aims for the Resource are to 1) continue to act as a strain repository accepting new strains and
making live cultures of T. thermophila available to interested users at reasonable cost; 2) complete the annotation
of archival strains currently housed at the Center and acquire next-generation cloning vectors for micro- and
macronuclear genome-editing; 3) offer expanded services and develop innovative marketing approaches to
increase revenues. Additionally, to ensure insure long-term stability of the resource we plan to 4) relocate the
repository from Cornell University to Washington University in St. Louis; 5) migrate all data from the legacy
Tetrahymena Genome Database (TGD) schema to CHADO and transfer its web-hosting functions from Bradley
University to the NSF-funded National Center for Genome Analysis Support (NCGAS) at Indiana University; and,
6) redesign the TGD website to display relevant data via the Tripal framework. Our additional Research aims
are to: 7) develop genetic strains lacking a functional ribosomal DNA locus to enable selection-free creation of
new cell lines; and, 8) develop CRISPR-mediated genome editing tools to enhance the overall utility of the
Tetrahymena platform.

Public health relevance
Project Narrative This project will support the use of Tetrahymena thermophila as a tool for basic and applied research. This organism has played a key role in our understanding of important biological processes including those underlying cancer, aging, fertility, respiratory and neuroendocrine function, and has practical applications as a manufacturing platform for vaccines and therapeutics proteins for the treatment of human disease.